Enhancing gnomAD Sustainability: Implementing Site Reliability Engineering Principles for Genomic Data Infrastructure

Project Summary
The gnomAD (Genome Aggregation Database) project is a large-scale effort to aggregate and harmonize
exome and genome sequencing data from diverse human populations, aiming to provide a comprehensive
resource to identify and interpret genetic variation in the human genome. gnomAD has become a critical
resource for scientists worldwide, enabling them to study the impact of genetic variation on human health and
disease.
The parent U24 award supports the gnomAD project by providing funding to (1) aggregate and produce
increasingly large datasets, (2) integrate gnomAD with other datasets, resources, and statistical tools, and (3)
disseminate the results to the wider research community. The parent award ensures the continued
development of a high-quality, variant database for researchers, empowering them to advance our
understanding of human genetics and contribute to the development of novel diagnostics and therapeutics.
This administrative supplement proposes to strengthen the gnomAD project's longevity by incorporating
Site Reliability Engineering (SRE) principles and practices. SRE is a new engineering discipline that was
invented at large technology companies to streamline management of computational infrastructure, but has not
yet seen widespread adoption in academia. The proposal's specific aims are twofold: the first aim involves
developing SRE practices within the gnomAD project by refactoring the existing codebase. This will improve
the project’s ability to meet unique challenges related to increasing data scale, manage computational
environments for the production/research teams, and meet users' expectations for a highly performant browser
resource. The second aim relates to creating high quality public documentation for our solutions and publishing
these in tool registries for other genomics projects to use, copy, and repurpose.

Public health relevance
Narrative This project aims to improve the Genome Aggregation Database (gnomAD), a vital resource for researchers studying genetic variation in human populations, by incorporating advanced Site Reliability Engineering practices. By enhancing the stability, performance, and scalability of the gnomAD resource, we will enable more efficient and reliable access to valuable genetic data for the scientific community. Our proposal will help secure the future of gnomAD, enabling researchers to continue deriving insights from human genetic variation, paving the way for personalized medicine, more accurate diagnoses, and targeted treatments, ultimately improving health and quality of life for the general public.